Implementing a dementia caregiver support strategy among Latinos in primary care

PROJECT SUMMARY/ABSTRACT: PROJECT 3 (PERALES-PUCHALT)
Latino caregivers of individuals with dementia (IWDs) experience disproportionate levels of stress, depression,
and poor access to caregiver community resources. Caregiver support interventions can reduce caregiver
stress by providing knowledge and skills regarding dementia, caregiving, available community resources, and
coping with stress. Unfortunately, most primary care clinics offer little in terms of caregiver support for their
patients with dementia. Community health workers (CHWs) are being used in many primary care clinics to
provide culturally tailored health education and connections with community resources, but to our knowledge
have not been specifically engaged in providing support for caregivers of IWDs. There is a unique opportunity
to engage CHWs in efforts to implement caregiver support interventions among Latinos in primary care. The
overall objective of this project is to inform the development of an implementation strategy in which CHWs
deliver ¡Unidos Podemos! among Latinos in primary care. ¡Unidos Podemos! is a culturally tailored evidence-
based caregiver support intervention for Latinos. We propose an implementation strategy that leverages CHWs
already working in primary care and provides them with the training, resources and ongoing support needed to
implement ¡Unidos Podemos!. On Aim 1 we will identify barriers and facilitators to the implementation of
¡Unidos Podemos! by CHWs among Latinos in primary care. On Aim 2 we will test the feasibility of a CHW-
support strategy for implementing ¡Unidos Podemos! among Latino caregivers in two primary care clinics.